DEVELOPMENT OF GENOMIC RESOURCES FOR THE PRAIRIE VOLE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. During the reporting period, we have completed the characterization of the prairie vole BAC library and published a paper describing the library. Using end sequencing of random BAC's we have identified more than 2000 SNPs in more than 300 loci. In addition, we have isolated BAC clones containing the genes for 20 behaviorally relevant genes (e.g. oxytocin, vasopress, CRF and their receptors, steroid receptor, etc), and a manuscript is in preparation describing these loci. Using the SNPs and a pedigree with more than 300 individual prairie voles we have created a first generation linkage map of the prairie vole genome. This map will be useful in assembling the prairie vole genome. The Broad Institute is currently sequencing the prairie vole genome.